Improved Motion Robust MRI of Children

Project Summary
Magnetic resonance imaging (MRI) is critically important for pediatric care. However, patient motion
significantly limits our ability to produce high-quality images in young children who may be unable to respond
well to verbal instructions and who have difficulty remaining still inside the scanner. Head motion during MRI
disrupts spatial encoding and leads to data loss, generating a range of artifacts in the images, which hinders
diagnostic utility. Thus, sedation and anesthesia are routinely used in pediatric populations; however, these
practices are associated with severe adverse events and are extremely time-consuming and costly to
administer. Unfortunately, current state-of-the-art motion compensation technologies are not fast or accurate
enough to adequately compensate for large and frequent head movements in uncooperative children, or
require external hardware, which is far from ideal for clinical workflow. Under the previous grant period, we
made significant progress towards our overarching goal of improved motion-robust pediatric MRI by
successfully developing a new markerless motion tracking approach utilizing free induction decay (FID)
navigators and novel algorithms to generate diagnostic images from small periods of motion-free time. The
goal of the research proposed under this renewed application to the NIH is two-fold: 1) to continue to develop
and refine novel markerless technologies for motion measurement and correction to enable high-quality MRI in
the presence of large, frequent motion and 2) to evaluate these technologies for improving the quality and
success rate of pediatric MRI without the use of sedation and anesthesia. We hypothesize that improving the
accuracy of FID navigator motion measurements, and the extent and speed of our correction algorithms, will
successfully compensate for sources of persistent artifacts in the images. To achieve these ambitious goals,
we propose to undertake the following Specific Aims over the 5-year period of requested support: 1) develop
and evaluate an extended model that can, for the first time, simultaneously measure head motion and induced
magnetic field changes using FID navigators; 2) develop and evaluate a novel self-navigated 3D radial
acquisition with augmented reconstruction for retrospective correction of motion, and induced magnetic field
and coil sensitivity variations; 3) develop and evaluate prospective motion correction and dynamic shimming
utilizing real-time motion and field measurements to produce artifact-free images; and 4) apply and evaluate
these highly innovative motion compensation techniques for imaging 0–8 year old patients without the use of
sedation. The motion-robust imaging technologies proposed in this application can be easily deployed in
clinical settings with widely-available, standard MRI hardware, and are therefore expected to have rapid
translational impact for the countless pediatric diseases and disorders presently evaluated by MRI. The ability
to image young children without the use of sedation and anesthesia will dramatically decrease the time, cost
and risk involved in generating diagnostically useful images with MRI.

Public health relevance
Project Narrative In radiology today, we are frustrated daily by our inability to obtain useful diagnostic images in young children, who are often unable to remain still for long scan durations, without resorting to the use of sedation or anesthesia, which unfortunately are associated with the possibility of serious adverse side effects and add significantly to the cost of imaging. Thus, there is an urgent, unmet need for accurate, safe and reliable imaging techniques to offset the effects of uncontrolled, fast motion in children, to produce images of superior diagnostic value without the use of sedation, leading to effective diagnosis, treatment and monitoring of pediatric disease. The proposed project, “Improved Motion Robust MRI of Children” promises to deliver a highly innovative imaging method capable of producing high-quality images in the presence of large and frequent motion by tracking the position of the head and updating the acquisition in real-time, which will in turn remove the need for sedation, effectively eliminating potentially life-threatening side effects from the imaging equation.